Computational Pathology High Performance Computing Cluster

Project Summary/Abstract
Genomics, digital imaging, and spatial biology technologies generate a large amount of data
that needs to be processed and analyzed with a high-performance computing (HPC) cluster.
Interpretation of these high dimensional data could be significantly enhanced with artificial
intelligence which also requires extensive data storage, high-speed network for data transfer,
and substantial CPU/GPU capacity for model training and inference.
The existing HPC cluster managed by Mass General Brigham (MGB) Enterprise Research
Information Systems (ERIS) is outdated with old technology that is further exacerbated by an
oversubscription of ERIS users competing for limited resources in the cluster. An alternative
research cluster in the Massachusetts Host-Microbiome Center (MHMC) also faces similar
issues with storage, networking, and limited GPU capacity. Recognizing these challenges, we
propose to build and support the MGB Pathology Research HPC cluster with ten CPU nodes,
seven petabytes of resilient TrueNAS storage, five H100 GPU nodes, and vast NVMe storage
technology all connected with a fast 200GbE ethernet storage networking and a modern
400GbE Infiniband fabric for GPU networking. We will use a software layer with Rancher,
Harvester, Longhorn, and Kubernetes to further ensure high availability, load balancing, and
ease of application orchestration.
This proposal has garnered the full support of MGB Digital and MGB Pathology leadership who
have committed in-kind salary support for an HPC Specialist, an Infrastructure Team Lead, and
an Infrastructure Engineer to help design, build, implement, and support the MGB
Computational Pathology HPC Cluster. Additionally, in-kind departmental funds under the
discretion of the PI and Co-I of this S10 High-End Instrumentation Grant (HEI) will further
ensure success for this project. This proposed platform will accelerate numerous Mass General
Brigham NIH-funded projects in genomics, spatial imaging, digital pathology, and AI, thereby
driving innovation and discovery in these fields as exemplified by the 21 projects proposed by 6
major and 4 minor users. The PI, Co-I, and Instrument Advisory Committee will ensure that this
system will be available to the broader MGB Pathology community and collaborators in the
Greater Boston region. This will enable high-performance computing for NIH-funded projects,
thereby fostering a collaborative and innovative research environment.

Public health relevance
Project Narrative In this S10 High-End Instrumentation (HEI) Grant application, we request funds to build and support a Computational Pathology High-Performance Computing Cluster that will facilitate data processing, analysis, and artificial intelligence across a wide range of data-intensive NIH-funded projects. This system would offer robust storage and computing capabilities to basic and translational researchers in the Mass General Brigham (MGB) community which otherwise would not be possible without a Shared Instrument Grant. The shared HPC cluster will be a transformative platform to catalyze a broad range of projects across MGB and in the Greater Boston region that are applying genomics, single-cell sequencing, spatial biology, digital pathology, and artificial intelligence.